VIS4ION-Thailand (Visually Impaired Smart Service System for Spatial Intelligence and Onboard Navigation) - Resub - 1

PROJECT SUMMARY/ABSTRACT
Visual impairment engenders mobility losses, debility, illness and premature mortality. These mobility losses
have been associated with unemployment rates that reach 80% globally and to severe compromises in quality
of life (QoL). In many cases, health and wellbeing are ‘attacked’ by vision loss in any form factor and psychosocial
barriers such as anxiety and depression are compounding influences that increase as deficits scale. The fear of
falling is a threat that contributes to this downward ‘spiral’ and often goes unchecked; this fear is alarmingly
justified, as visual impairment precipitates substantial increases in mechanical trips, falls and long-bone factures.
This perfect storm leaves considerable swaths of the population poor, disenfranchised, and experiencing
adverse health outcomes. These startling facts, although true in almost every high-income country, are even
more severe in low- and middle-income countries, such as Thailand. When considered at a basic functional level,
visual impairment destroys access to information about our three-dimensional world and the objects in it, leading
to poor spatial cognition and an inability to navigate successfully, whether that be to a place of employment or a
grocery store. Advanced wearables provide a potential solution to close this gap and provide consistent and
reliable access to the information needed for mobility and orientation during navigation. Our team was
instrumental in developing a novel wearable - VIS4ION (Visually Impaired Smart Service System for Spatial
Intelligence and Onboard Navigation), a personal mobility solution that serves as a customizable, human-in-the-
loop, sensing-to-feedback platform to deliver functional assistance in real-time. Our central hypothesis is that
wearables support spatial cognition in visually impaired (VI) populations, augmenting personal freedom and
agency, and promoting health and wellbeing. We seek to enhance this technology with next-generation mapping
and localization software fashioned into a microservice to support spatial cognition in the VI. We will assess the
performance of this new approach (e.g., mapping) as well as its impact on function (e.g., navigation efficiency),
health (e.g., falls), and wellness (e.g., QoL) metrics. The proposal has five aims in two phases focused on
validating this approach in a global setting. First, we will implement semantic segmentation and image-query-
based localization networks in a small Thai campus to operate independently of both environmental (sensor-
based) and Wi-Fi/cell infrastructure. We will then deploy this augmented platform with VI students. Third, we will
assess for acceptability, appropriateness, and feasibility, focusing on experiences with VIS4ION. If milestones
are met for this first phase (R21), we will progress to the second phase (R33). Fourth, we will test the
effectiveness of the improved system over an extended-use period. Lastly, an additional urban area in Bangkok
will be selected and 3D environmental map built for generalizability testing, ensuring that VIS4ION is able to
handle multiple locations with disparate contextual elements. Given this foundation and planned advances, we
predict the platform will substantially mitigate fall and immobility risks and associated adverse health outcomes.

Public health relevance
PROJECT NARRATIVE The burden of visual disability in the U.S. is substantial, and the challenges confronted by several population subgroups are similar to those with visual disability in Thailand. We will use next-generation mapping and localization technology to support microservices that are embedded in a novel wearable, serving as a smart service system to improve the mobility and health of individuals in these populations. Our transdisciplinary and global team will use a patient-centered approach that leverages input from study participants and visual disability experts for improved function and usability, ultimately benefitting visually impaired persons worldwide.